ADHESIN-BASED NANOTHERAPEUTICS IN URINARY TRACT INFECTION

DESCRIPTION (provided by applicant): The need for new anti-infective agents and strategies is underscored by recent acceleration in bacterial resistance to existing antibiotics and the exhaustion of currently known targets of microbial cell biology and biochemistry. Further anti-infectives development will be driven by discovery of the pathogenic molecular processes of infectious diseases, which are often initiated by host-pathogen encounters at epithelial surfaces. Urinary tract infections (UTIs), a major source of morbidity and medical costs worldwide, are caused primarily by uropathogenic Escherichia coli, which employ an adhesive fiber termed the type 1 pilus to bind and invade bladder epithelial cells. Recurrences are common after acute UTI, and recent data suggest that bacteria establish chronic residence within bladder tissue, resist oral antibiotic therapy, and re-emerge to cause these recurrences. In this application, we propose to deliver anti-infective agents into epithelial cells via the conjugation of antimicrobial-bearing polymer nanoparticles (NPs) with a bacterial adhesin, a protein that confers epithelial binding and invasion capacity upon our model Gram-negative pathogen. Our first objective will be to refine the chemical processes by which a subject protein (specifically the binding domain of the E. coli type 1 pilus adhesin FimH) can be conjugated with favorable orientation and distribution to the exterior of a series of polymer NPs. Second, we will demonstrate the adhesin-dependent internalization of these functionalized NPs into bladder epithelial cells in vitro and in vivo, providing uniquely available controls to prove the specificity of the adhesin-receptor interaction. Third, we will optimize the loading of silver cation and structurally modifiable silver carbene antimicrobials into the NPs. Finally, we propose to demonstrate the anti-infective activity of these antimicrobial-bearing, adhesin-coupled NPs, both in vitro and in murine models of acute and chronic cystitis caused by uropathogenic E. coli. Advantages of this system include the capability to deliver antimicrobials in high concentration to the intracellular compartment where pathogens may reside, avoidance of toxicities associated with systemic antibiotic and NP administration, and flexibility in the structural design of both the protein coat and the antimicrobial passenger. Though we will model the utility of our system using bacterial infection of the mammalian urinary tract, the delivery of pharmacologic agents of choice into selected epithelial cell populations will have broader applications spanning infectious diseases, cancer, and vaccine antigen delivery.

Public health relevance
PUBLIC HEALTH RELEVANCE: Recurrent urinary tract infection (UTI) plagues many otherwise healthy women and complicates other urinary tract conditions. We propose to develop nanoscopic particles bearing silver-based antibacterial agents and coated with a bacterial protein to confer adhesion to the bladder surface. We will evaluate the ability of these nanoparticles to prevent and treat UTI. NARRATIVE Recurrent urinary tract infection (UTI) plagues many otherwise healthy women and complicates other urinary tract conditions. We propose to develop nanoscopic particles bearing silver-based antibacterial agents and coated with a bacterial protein to confer adhesion to the bladder surface. We will evaluate the ability of these nanoparticles to prevent and treat UTI. __SpecificAimsTextDelimiter__ 2. SPECIFIC AIMS Because our epithelial surfaces are constantly exposed to the environment, these surfaces represent the site of numerous encounters between hosts and potential pathogens. Bacterial and viral pathogens commonly attach to and invade the cells of these epithelia, triggering transcriptional and biochemical programs in both host and pathogen that initiate the infectious syndromes that we recognize clinically. Recent advances in our comprehension of these pathogenic processes with molecular resolution now afford the opportunity to employ this knowledge in developing novel therapeutic strategies. In this application, we propose to deliver anti-infective agents directly to the sites of origin of infectious diseases by conjugating antimicrobial-bearing polymer nanoparticles with a bacterial adhesin, a protein that confers epithelial binding and invasion capacity upon our model Gram-negative pathogen, uropathogenic Escherichia coli (UPEC). The predominant cause of bacterial cystitis, UPEC express adhesive surface fibers termed type 1 pili, which are necessary and sufficient to mediate binding and invasion of mammalian bladder epithelial cells. After replicating intracellularly into large biofilm-like masses called intracellular bacterial communities (IBCs), UPEC establish a quiescent intracellular niche from which they later re-emerge to cause recurrences of cystitis. This intracellular reservoir is undetected by host immunity and resistant to therapy with traditional antibiotics. Our primary goal is to eradicate this reservoir with antibacterial silver, delivered to the intracellular compartment by nanoparticles whose surfaces are covalently decorated with the UPEC type 1 pilus adhesin. Advantages of this system include targeted delivery of antimicrobials in high concentration to the location where pathogens reside, avoidance of toxicities associated with systemic antibiotic and nanoparticle administration, and flexibility in the structural design of both the protein coat and the antimicrobial passenger. Though we will model the utility of our system using bacterial infection of the mammalian urinary tract, the concepts have broader applications spanning infectious diseases, cancer (particularly epithelial tumors), and vaccine antigen delivery. The specific aims of this proposal are: 1. Refine the chemical processes by which a bacterial adhesin can be conjugated to polymer nanoparticles (NPs). We hypothesize that the uropathogenic Escherichia coli type 1 pilus adhesin FimH can be covalently attached to polymer NPs, and that this conjugation will confer epithelial binding and internalization upon the NPs. A primary chemical strategy for covalent binding of the adhesin to NP shells has been identified, in addition to several alternatives. The efficiency of conjugation will be determined by immunogold electron microscopy and other techniques, and the properties of these adhesin-coupled NPs will be assessed using in vitro and in vivo epithelial models. 2. Incorporate antibacterial silver (Ag+) into adhesin-based therapeutics. A nanostructural device bound to an epithelial surface could be used to achieve a high and durable local concentration of therapeutic agents. In accordance with our focus and experience, we propose to introduce silver, a broadly active antimicrobial agent that has elicited resistance only rarely, into the NPs. Our preliminary work favors the approach of chelating Ag+ into the NP shell; we will also pursue loading of the NP core with engineered silver carbene (SC) antimicrobials, structurally optimized for such an application. 3. Demonstrate anti-infective activity of these novel agents in models of urinary tract infection. Recent knowledge regarding the course of UTI pathogenesis reveals several stages at which adhesin-based therapeutics might be applied. Specifically, uropathogenic E. coli employ type 1 pili to bind and invade the bladder epithelium, then multiply rapidly within superficial epithelial cells, establishing a chronic intracellular reservoir that can serve as a seed for recurrent UTI. We propose to discover whether the biocidal, functionalized NPs can ameliorate recurrent UTI (by eradicating chronically resident bacteria from the bladder epithelium) or prevent establishment of UTI in murine models.